Advanced machine learning to empower ultra-sensitive liquid biopsy in melanoma and non-small cell lung cancer

Research: The ability to monitor malignant tumor burden below the limit of radiographic detection remains a
major unmet need. Liquid biopsy for circulating tumor DNA (ctDNA) offers promise, however, deep targeted
sequencing methods – the conventional approach in the field – face a sensitivity plateau in low volume cancer
due to the sparsity of ctDNA signal. Whole genome sequencing (WGS) of plasma overcomes this sensitivity
barrier by expanding the number of informative sites to the thousands of somatic single nucleotide variants
observed across the genome in solid tumors. We showed with our tumor-informed MRDetect framework that
WGS of plasma can increase liquid biopsy sensitivity by 1-2 orders of magnitude beyond deep targeted
sequencing methods. To expand applicability and overcome MRDetect’s need for matched tumor tissue, I built
MRD-EDGE, a plasma-only (de novo) classifier that uses advanced machine learning to increase error
suppression and amplify ctDNA signal. My preliminary data shows that MRD-EDGE can quantify ctDNA tumor
burden during the nadir of response to immunotherapy in patients with advanced melanoma, and can
demonstrate a response to treatment as early as 3 weeks after first infusion. MRD-EDGE therefore enables
precise monitoring of malignant disease burden in response to therapy using standard WGS alone.
In this proposal, I aim to first radically improve MRD-EDGE sensitivity by including epigenetic features that
inform likelihood of cancer mutagenesis, which I hypothesize will allow for unprecedented plasma-only liquid
biopsy sensitivity. I will then use the optimized MRD-EDGE platform to define early response or resistance to
immunotherapy in metastatic melanoma, which will establish ctDNA as a biomarker that can complement or
replace imaging. Finally, I will optimize MRD-EDGE for use in lung cancer and use the platform to monitor
response to neoadjuvant immunotherapy and detect postoperative minimal residual disease. I expect that
ultra-sensitive monitoring of ctDNA dynamics in the neoadjuvant period can guide precision adjuvant therapy in
the postoperative period and thereby provide a transformative impact on patient care.
Candidate: I am an Instructor of Medicine at Memorial Sloan Kettering Cancer Center (MSK) and a Visiting
Fellow at the New York Genome Center (NYGC). I have outlined a 5-year career development plan to
transition to an independent, tenure-track physician-scientist investigating the detection and monitoring of solid
tumors through ultrasensitive liquid biopsy. I will conduct the proposed research under the mentorship of Dr.
Dan Landau, an internationally recognized expert in liquid biopsy and cancer genomics. I will use the K08
award to further develop skills in next-generation sequencing methods and analysis and advanced machine
learning. MSK and the NYGC are ideal environments in which to pursue my scientific and career goals. Both
institutions have world class research communities and an outstanding track record of training independent
physician-scientists.

Public health relevance
PROJECT NARRATIVE Conventional deep targeted sequencing approaches to liquid biopsy for circulating tumor DNA (ctDNA) face fundamental sensitivity barriers in low volume disease, which largely restricts use of liquid biopsy to advanced malignancy. Recently, we demonstrated that use of whole genome sequencing (WGS) of plasma can overcome prevailing sensitivity barriers in liquid biopsy through use of advanced error suppression and matched tumor tissue, allowing for detection of postoperative minimal residual disease (MRD) that was linked to early cancer recurrence in non-small cell lung cancer and colorectal cancer. In this proposal, I seek to use advanced machine learning to overcome matched tumor tissue dependency and vastly expand the applicability of our WGS-based approach, which will enable ultrasensitive therapeutic monitoring of response to immunotherapy and detection of postoperative MRD with plasma WGS alone.